Investigating the role of OAADPr-ACADM interaction in colorectal cancer

Project Summary/Abstract
Nicotinamide Adenine Dinucleotide (NAD+) serves as a crucial redox cofactor in metabolism and acts as a
substrate for poly (ADP-ribose) polymerase and sirtuins, playing roles in DNA repair, metabolism, and stress
response and involving in cancer and longevity. Sirtuins consume NAD+ and produce a unique byproduct, O-
acetyl-ADP-ribose (OAADPr), which holds significant potential as a signaling molecule in regulating various
biological processes. Yet, the biological roles and metabolic regulations of OAADPr remain poorly elucidated.
Colorectal cancer (CRC) is the third leading cause of cancer deaths in the United States. The poor outcome of
CRC highlights an urgent need to identify mechanisms that regulate CRC metabolism and growth. Studies have
shown elevated NAD+ levels and increased expression of NAD+ biosynthesis and salvage enzymes in CRC,
suggesting a critical role of NAD+ metabolism in CRC progression. Sirtuins are involved in CRC and conflicting
roles have been reported in CRC. Yet, the mechanistic links between sirtuins and cancer remain incompletely
understood and the exact mechanistic links between NAD+-related metabolites and cancer remain unclear.
To identify novel proteins that interact with NAD+-metabolites, I applied a proteomic thermal stability assay and
discovered a previously unknown interaction between medium-chain specific acyl-CoA dehydrogenase (ACADM)
and OAADPr. ACADM is a key enzyme in β-oxidation, and aberrant fat metabolism has long been recognized in
CRC. I hypothesize that OAADPr may play a tumor-suppressive role in CRC through the inhibition of ACADM
activity and fat utilization. I will test this hypothesis in two aims: 1) elucidate the mechanism of how OAADPr
affects ACADM activity and 2) examine the impact of OAADPr-mediated inhibition on ACADM both in vitro and
in vivo. In Aim 1, I will determine the kinetic and equilibrium parameters of the inhibition of OAADPr on ACADM
and its mechanism. In Aim 2, I will modulate OAADPr levels in CRC cells by overexpressing (OE) SIRT3 and/or
knockout (KO) MACROD1, two key enzymes that regulate OAADPr metabolism. With that, I will first assess fat
oxidation in wild-type, SIRT3 OE, and/or MACROD1 KO CRC cells by measuring the rate of fatty acid oxidation,
profiling acyl-carnitines, and conducting C13-palmitate tracing experiments. Then, I will assess if OAADPr
modulates CRC proliferation and tumor growth by measuring cell proliferation in vitro, organoid growth ex vivo,
and xenograft or spontaneous tumor growth in vivo with altered OAADPr levels. Lastly, I will investigate whether
dietary supplementation of NAD+ precursors affects intratumor OAADPr levels and tumor growth in organoids
and the genetically engineered mouse model.
Our research is conceptually novel and will address an important gap in our understanding of the mechanism by
which NAD+ metabolism affects tumor proliferation. The proposed study will also uncover new roles for OAADPr
in metabolism and cancer and open a new area in NAD+ and sirtuin biology. The insight gained may open
avenues for novel approaches leveraging NAD+ metabolism in cancer therapy.

Public health relevance
Project Narrative NAD+ plays a critical role in metabolism and NAD+ levels and its metabolism are altered in cancer; yet, the mechanistic links between NAD+ and NAD+-derived metabolites and cancer remain incompletely understood. By employing a novel proteomic screening assay, I identified a previously unknown interaction between NAD+- derived sirtuin byproduct OAADPr and ACADM, a key metabolic enzyme involved in fatty acid oxidation. The goals of our studies are to identify the mechanism by which OAADPr regulates ACADM activity and assess the effects of OAADPr modulation on fat oxidation and tumor growth.